Core B: Organoid Core

PROJECT SUMMARY (Core B: Organoid Core)
Infectious disease research is substantially hampered by lack of experimental models necessary to study
interactions between pathogens and target tissues; a glaring deficiency amplified by the recent COVID-19
pandemic. The recent advent of 3D organoid methods embodies a more physiologic in vitro infectious disease
platform. Over the past 5 years, the Stanford NAMSED U19 Center has operated an Organoid Core, led by
Calvin Kuo, which has distributed approximately 74 organoid lines for modeling infectivity of gastrointestinal
pathogens, resulting in numerous collaborative publications. The Organoid Core has also produced new air-
liquid interface (ALI) organoids that maintain epithelium and infiltrating immune populations en bloc without
reconstitution (Cell, 2018) and created new protocols for long-term, feeder-free, chemically defined human lung
distal organoid culture, as well as novel human nasal sinus organoids (Cell Stem Cell, 2020).
The overall goal for Core B (Organoid Core) in our renewal application of the Stanford NAMSED U19 for
a Stanford/UNC Biomimetic U19 Research Center is to expand upon our previous success and provide novel
ex vivo models for studying gastrointestinal and respiratory pathogens. Thus, Core B will serve as a central
biohub for our Center by generating and distributing next-generation human gastrointestinal and respiratory
organoid cultures to support Projects 1-3. In addition to these core responsibilities, the Kuo lab will optimize
innovative organoid-based assays that will provide additional support for Projects 1-3 and resources for the
global research community. In Aim 1, human “epithelial-only” organoids from the stomach, small intestine, distal
lung and nasal airways will be generated, characterized, and distributed for Project 1 (H. pylori, S. Typhi, S.
Typhimurium), Project 2 (rotavirus), and Project 3 (SARS-CoV-2, MERS, pre-epidemic coronaviruses and 1918
influenza H1N1 virus). There has been a particular lack of organoid methods incorporating endogenous immune
populations without reconstitution. Thus, Aim 2 develops innovative ALI organoid methods preserving epithelial
and endogenous infiltrating immune cells en bloc for defining cross-talk between epithelial and immune
compartments during GI and pulmonary infections. Lastly, Aim 3 optimizes multiplexed organoid platforms for
pathogen infection and drug screening to provide novel methods for evaluating infection, therapeutics and
immune responses.
Overall, Core B of the Stanford/UNC Biomimetic U19 Research Center leverages leading-edge expertise
in primary 3D human organoid culture for the study of enteric and respiratory pathogens. Additionally, we
capitalize on novel organoid methods preserving both the epitheilal and immune components to provide
innovative holistic tools to dissect pathways involved during pathogenic infection, with both basic and
translational implications.